Mechanisms of Neurodegeneration in KIF5A ALS/FTD

Amyotrophic Lateral Sclerosis (ALS) is a fatal disease characterized by the dysfunction and death of motor
neurons. Some ALS patients develop widespread neuronal damage leading to Frontotemporal Dementia (FTD),
which is characterized by progressive behavioral change and language decline. Significant overlap exists
between ALS and FTD regarding the genetic causes, suggesting that they may share common pathogenic
mechanisms. Recently, mutations in motor protein, KIF5A, were identified in patients with ALS, ALS/FTD, and
FTD alone. These concentrate in the splicing regulatory sites flanking exon 27 leading to its exclusion and
abnormal KIF5A C-terminal domain structure. Our preliminary findings suggest that KIF5A ALS/FTD mutations
result in the production of a constitutively active protein that causes disease through toxic gain of function. This
proposal will test the hypothesis that KIF5A ALS/FTD is caused by gain of function of KIF5A activity in axonal
transport and cytoskeletal regulation. To ensure that our work will be highly disease relevant we will utilize human
iPSC derived motor neurons and mouse models harboring KIF5A ALS/FTD mutation. In Aim 1: we will define
the effects of KIF5A ALS mutations on the assembly and motility of motor/cargo complexes. Specifically, we will
utilize live-cell imaging of cargo motility, assessment of cargo distribution by IHC and transmission electron
microscopy (TEM), candidate-based biochemical assessment of interactions with cargo adaptors, and unbiased
assessment of interactions with potentially novel cargo adaptors and regulatory proteins using proximity labelling.
In Aim 2: we will characterize the effects of KIF5A ALS/FTD mutation on cytoskeletal structure using IHC and
TEM, live-imaging of MT dynamics and sliding, and analysis of MT post-translational modifications. In Aim 3: we
will develop a mouse model of KIF5A ALS/FTD and perform analysis of longevity, behavior, and pathology. The
mouse model will be an invaluable resource to validate findings from our in vitro studies and to advance
knowledge regarding key features of neurodegeneration in KIF5A ALS/FTD. My ultimate goal is to become a
successful physician-scientist with an independent research program investigating the mechanisms of
neurodegeneration in motor neuron disease with a specific focus on axonal transport and cytoskeletal dynamics.
Northwestern University has unique strengths in the study of ALS, FTD, and cytoskeletal biology and an
outstanding commitment to the development of physician-scientists. The mentorship team includes renowned
scientists with strong records in mentorship including Han-Xiang Deng M.D., Ph.D. (Primary Mentor) and Robert
Kalb M.D (co-mentor). The career development plan focuses on broadening the awardee’s portfolio of research
publications and presentations, which will be necessary for successful competition for RO1 funding. Career
development activities will bolster grantsmanship and manuscript preparation skills and provide extensive
didactic training in advanced imaging techniques, proteomics, cytoskeletal biology and ALS/FTD degenerative
mechanisms.

Public health relevance
Gain of function mutations in motor protein KIF5A are an emerging cause of pathogenesis in Amyotrophic Lateral Sclerosis (ALS) and Frontotemporal Degeneration (FTD). This proposal investigates how ALS/FTD causative mutations in KIF5A affect its function in axonal transport and cytoskeletal regulation. Our findings will provide insights into the critical roles KIF5A in neuronal health and lay the foundation for rational design of therapeutics to treat KIF5A ALS/FTD.